Epigenetic regulation of sexually dimorphic immune responses in keratinocytes

PROJECT SUMMARY
Dysregulation of inflammatory responses are observed in a variety of cutaneous diseases, including
autoimmune diseases and infections. A striking feature of these conditions is sexual dimorphism relating to the
differential incident rates of these diseases between women and men. Understanding the underlying
mechanism for the sex-biased inflammatory responses can point towards previously unappreciated pathways
that are critical in regulating immune responses, and therefor can lead to development of sex-specific
therapeutic approaches. Current data on the effect of sex-hormones and sex-chromosome regulatory genes
insufficiently explain these biologic differences between men and women. We have recently identified
differential epigenetic modifications between male and female keratinocytes, setting the stage for our
hypothesis that sexually dimorphic epigenetic modifications in keratinocytes affect immune gene
transcription and responses. The objective of this project is to identify and target epigenetic modifications
that drive sexually dimorphic immune responses, allowing future development of precision therapies for
inflammatory skin disorders. Upon the successful completion of this project, we will have characterized
epigenetic differences between skin cells in women and men, determined the contribution of these sex-biased
epigenetic modifications to immunological responses, and assessed whether they could serve as therapeutic
targets for future treatment of immune mediated skin disorders.

Public health relevance
PROJECT NARRATIVE Sexual dimorphism is observed in various immune disorders of the skin, but the mechanism involved are unknown. The objective of this project is to identify and target epigenetic modifications that drive sexually dimorphic immune responses. This work can lead to identification of novel therapeutic targets in various sex- biased skin immune disorders.